Biostatistics Core

The primary objective of the Biostatistics Core B is to contribute to the science and operation of the program
project by participating fully in its activities as it has for the preparation of this application. This includes
assistance and direction in experimental design, data collection and management, quality control, statistical
data analysis, and interpretation of findings through consultation and collaboration; inventing and incorporating
new and novel procedures as needed. The team that helps prepare the application and will provide
biostatistical supports for this program project consists of the following statisticians from the University of
Minnesota and the Masonic Cancer Center: Chap Le (Core Director, with primary responsibility on statistical
methodologies), Todd DeFor (Project 1, expertise focused on clinical trial), Xianghua Luo (Project 2, expertise
focused on experiment design and survival analysis, Saonli Basu (Project 3, expertise focused on genetics
issues and genetic statistics). These four statisticians are assisted by two highly experienced experts on data
analysis (Qing Cao and Ryan Shanley).

Public health relevance
The primary objective of the Biostatistics Core B is to contribute to the science and operation of the program project by participating fully in its activities as it has for the preparation of this application. This includes assistance and direction in experimental design, data collection and management, quality control, statistical data analysis, and interpretation of findings through consultation and collaboration; inventing and incorporating new and novel procedures as needed.